Development of Live Microbiome-Based Products: Fecal Microbiota for Transplantation (FMT) and Live Biotherapeutic Products (LBPs)

To facilitate the development of microbiome-based products, Fecal Microbiota Transplant (FMT) and Live Biotherapeutic Products (LBPs).